Developing Future Leaders in Nephrology

Project Summary/Abstract Women and underrepresented minorities are poorly represented among the leadership in science and medicine, a trend that also applies to nephrology. The reasons for this discrepancy are multifactorial and include limited opportunities for junior nephrology professionals to network and learn leadership skills from successful men and women in academic medicine. Women in Nephrology (WIN) has a long history of providing Professional Development Seminars (1999-2014) and leadership lectures (2015-present) to the nephrology community. WIN will use its extensive network of leaders and mentors in nephrology to organize a one-day conference on “Developing Future Leaders in Nephrology” planned for September 24, 2021 in Birmingham, AL at the University of Alabama at Birmingham. This WIN-sponsored leadership conference for junior nephrology professionals will foster networking with senior leaders, provide strategies for overcoming barriers to effective leadership, such as imposter syndrome and unconscious bias, a platform for attendees to present their research and obtain constructive criticism, and opportunities to harness social media to promote leadership branding in academic medicine. The goal is to provide men and women, particularly those from underrepresented minorities, with tools to succeed in leadership. The agenda will include leaders in academic medicine, pharmaceutical industry, and private practice and opportunities for junior professionals to form valuable contacts with other peers across the country. Importantly, this conference directly responds to Goal 4, “Promote training and careers to develop a well-trained, diverse, and robust workforce to advance science for the health of women”, of the Office of Research on Women’s Health 2019-2023 Trans-NIH Strategic Plan for Women’s Health Research. In addition, it reflects the Scientific Workforce Diversity Office’s “effort to diversify the national scientific workforce and expand recruitment and retention”. These are critical needs for junior nephrology professionals that have not been fully realized by societies and industry.

Public health relevance
Project Narrative Women in Nephrology (WIN) is proposing a one-day conference, “Developing Future Leaders in Nephrology” at University of Alabama at Birmingham targeting junior nephrology professionals that will prepare and empower a diverse nephrology work force to effectively take advantage of leadership opportunities. This meeting will address barriers to leadership such as unconscious bias and imposter syndrome, promote networking with senior leaders in nephrology, and provide instruction on the use of novel tools, such as social media to improve leadership branding. WIN has a longstanding history of providing professional development and has put together a list of speakers who represent leaders in the American Society of Nephrology, International Society of Nephrology, American Physiological Society, and American Society of Clinical Investigation.